Non-invasive functional assessment and pathogenesis of Morquio A

7. Project Summary/Abstract
Mucopolysaccharidosis IVA (MPS IVA, Morquio A Disease) is a rare autosomal recessive disorder caused by a
deficiency of the lysosomal enzyme, N-acetylgalactosamine 6-sulfate sulfatase (GALNS). GALNS catalyzes
the degradation of the glycosaminoglycans: keratan sulfate (KS) and chondroitin-6-sulfate (C6S). MPS IVA
patients develop a characteristic skeletal dysplasia due to the progressive storage of KS and C6S. Patients
appear healthy at birth, although some patients present with abnormal skeletal dysplasia even at birth. Patients
usually come to medical attention within two years of life because of short trunk dwarfism, odontoid hypoplasia,
pectus carinatum, kyphosis, genu valgum, or hypermobile joints. Patients with severe phenotype often do not
survive beyond a few decades of life because of cervical instability/stenosis, tracheal obstruction, and
cardiopulmonary compromise. Patients require multiple orthopedic surgeries (cervical decompression/fusion,
osteotomy, hip reconstruction and replacement, etc.) throughout their lifetime. Enzyme replacement therapy
and hematopoietic stem cell therapy are available clinically. Gene therapy and enzyme degradation substrate
therapy are under development. In 1998, we began collecting medical information from patients in the Registry
Database. The database contains around 400 patients and has established a growth chart that indicates
marked poor growth with the imbalance and consequent poor health in MPS IVA. However, since these data
are based on responses to a self-completion questionnaire, there are inherent limitations to the data and their
interpretation. Current clinical assessments of therapies for MPS IVA patients are a 6-min walk test, a 3-min
stair climb test, and forced pulmonary function test. These endurance tests are difficult for small children,
patients in wheelchairs, and patients undergoing surgical procedures. Methods used to assess skeletal
dysplasia disorders can be expensive, time-consuming, and exhausting for the patients. Better methods for
assessment, including in-home evaluations, are needed to evaluate clinical efficacy and to provide optimal
clinical treatments for MPS IVA patients. The proposed project will assess multiple domains non-invasively,
which includes pulmonary function, bone mineralization, gait pattern, laxity of joints, tracheal function, and
hearing function. Proposed non-invasive assessments will provide an effective and innovative way of
characterizing the disease and evaluating the benefits of therapies even in small but diverse patient
populations despite age and physical handicaps. Over 100 MPS IVA patients have been enrolled in our clinic,
making our institution the most popular site in the world and ideally suited to complete this project. The
assessment program with non-invasive methods will have a significant impact on science and health by
detailing the progression and pathogenesis of major skeletal problems in MPS IVA. The outcome of this project
will also define clinical endpoints to measure the efficacy of future clinical products and interventions and may
apply to other skeletal dysplasias.
1

Public health relevance
8. Project Narrative Morquio A disease is a devastating systemic skeletal disease in which detailed progression and pathogenesis remain unknown. The proposed project aims to establish a non-invasive objective assessment that can be applicable to all ages of patients to better understand the progress of their disease and the most serious clinical problems (cervical instability and stenosis, tracheal obstruction, hyperlaxity of joints, hip dysplasia, and small lung capacity). The outcome of this project will lead to a more precise understanding of the skeletal/pulmonary compromise and defining clinical endpoints in this disease for future clinical trials of current or developing therapies. 1